Deep Learning To Automate Late Mechanical Activation Detection From Cardiac Magnetic Resonance Images

Project summary:
This proposal aims to develop advanced machine learning and artificial intelligence (ML/AI)
techniques to rapidly and accurately identify sites with late mechanical activation (LMA) and
compute circumferential uniformity estimate with singular value decomposition (CURE-SVD) from
standard cine cardiac magnetic resonance (CMR) images. Our long-term goal is to develop
networks that can determine LMA sites / CURE-SVD automatically from cine images acquired at
any CMR facility worldwide, thereby addressing a critical need in the effective guidance of device-
based therapies, such as Cardiac resynchronization therapy (CRT), for potentially millions of heart
failure patients. To accomplish this goal, we will make use of a rich and unique dataset we have
assembled at our institution based on over 200 patients undergoing CRT with a median follow-up
of five years. The data set includes demographics and comorbid diseases from EHR review, pre-
CRT/post-CRT imaging with CMR cine/DENSE/LGE (late gadolinium enhancement),
echocardiography, and multidimensional response parameters based on overall survival, serum
B-type natriuretic peptide testing, quality of life questionnaires, and exercise testing for peak VO2.
The central hypothesis of this proposal is that these ML/AI methods will effectively identify the
characteristics of scar-free LMA sites from cine imaging, achieving excellent agreement
compared with the original DENSE-based assessments, and predict post-CRT outcomes. Our
specific aims are (i) identifying LMA sites and computing CURE-SVD by developing joint neural
networks with inputs from cine SSFP/GRE images, (ii) with the addition of scar from LGE in the
network, we will develop a novel multi-task learning to consider scar information in the
determination of LMA sites free of scar, and (iii) comparing the performance of our proposed
methods with ground truth DENSE and results obtained from commercial feature tracking
software to predict CRT outcomes in the dataset with 200+ CRT patients with complete CRT
response data and long-term follow-up for survival and arrhythmia outcomes.

Public health relevance
Project Narrative: The objective of this work is to develop novel applications of deep neural networks leveraging ground truth cine DENSE data in order to provide a novel approach to extracting data from cine imaging through machine learning methods, and the application of these methods to a rich dataset with complete CMR, response, and survival data. We expect the results to be highly impactful by providing a new paradigm for imaging-based guidance for CRT patient selection and procedure implementation for use in CMR centers worldwide with or without DENSE.